Leadership, Planning and Evaluation

LEADERSHIP, PLANNING & EVALUATION
PROJECT SUMMARY/ABSTRACT
The Chao Family Comprehensive Cancer Center (CFCCC) has established leadership, planning, and evaluation
processes that have significant impact on the CFCCC's development, growth, and ability to capitalize on strategic
opportunities. The CFCCC performs regular needs assessments and evaluations that are vitally important to
strengthen its basic, translational, clinical, and population sciences research, training and education, and
outreach efforts, all of which serve the needs of the CFCCC Catchment Area of Orange County.
The Associate Director's Committee, Program Leaders and Shared Resources Committee, and the Senior
Leadership Council are internal groups that serve as decision-making bodies for the CFCCC. The External
Advisory Board (EAB), Internal Advisory Board (IAB), and Community Equity Board (CEB) provide critical
feedback and advice to aid the CFCCC in planning and evaluation activities, with the CEB bringing perspective
from the community to the CFCCC's efforts. Through these groups, the CFCCC develops coordinated plans,
evaluates progress, addresses challenges, identifies opportunities, and maximizes potential impact. Evaluation
is a priority for the CFCCC and is used to ensure that resources and efforts are aligned with CFCCC priorities
and strategic planning. Based on input from advisory boards the CFCCC has strategically reviewed Cancer
Center membership, and evaluated and improved CFCCC Programs and Shared Resources.
On an ongoing basis, and re-evaluated every five years, the CFCCC engages in a detailed process of strategic
planning. Most recently, the 2020-2025 Strategic Plan was finalized and forward action on individual tactics has
progressed. Implementation of the 2020-2025 CFCCC Strategic Plan is integrally woven into the overall planning
and evaluation processes of the Cancer Center.
The Specific Aims of Leadership, Planning & Evaluation are to facilitate CFCCC growth with a transdisciplinary
leadership team to guide and encourage cancer research collaborations and foster research discovery,
proactively establish CFCCC priorities and implement goals, strategies, and tactics, and ensure progress with
continuous assessment and thorough evaluation to match resources toward established goals.

Public health relevance
LEADERSHIP, PLANNING & EVALUATION PROJECT NARRATIVE Per PAR-20-043, a Project Narrative is not required for this component.